Chemistry Disciple B Track 2 Human Food Testing

Project Summary The Michigan Department of Agriculture and Rural Development (MDARD) Food, Fuel, and Disease section performs testing for mycotoxins; veterinary drugs;, Patulin, pH, aW, Total Dissolved Solids, meat fat, nutrient and heavy metals, filth, unidentified materials, fish speciation, histamine, and cannabidiol potency in food products. Through this funding opportunity the MDARD-FFD section intends work with interdepartmental agencies to increase sample volume (over 500 samples/year) and commodity type (spices, juices, CBD/THC edibles, aquaculture). The section also intends to add additional analytical methods and analytes to its human food testing program. Through discipline B, track 4 the section intends to implement a robust allergen testing program, and a more aggressive economic fraud program using advancing technologies and methodologies.

Public health relevance
CHEMISTRY TRACK 2 PROJECT NARRATIVE: The Michigan Department of Agriculture and Rural Development (MDARD) Food, Fuel, and Disease section intends to improve food testing surveillance program through the chemical analysis of food products and the enhancement of the technologies and methods currently employed by the section. The laboratory plans to/could test these commodities for mycotoxins, veterinary drug residues, toxic elements, nutrition, filth, and/or other emerging food safety issues.